Rhesus HHV-8 homologue in AIDS-related malignancies

? DESCRIPTION (provided by applicant): Viruses cause an array of disease manifestations ranging from acute respiratory disease, intestinal diarrhea, hemorrhagic fevers, hepatitis, cancer, and chronic autoimmune disease and in some instances death. One virus that was recently identified to be associated with cancer in human in 1995 is human herpesvirus 8(HHV8)/Kaposi's sarcoma-associated herpesvirus (KSHV). An accumulation of scientific evidence substantiates HHV8 as the etiological agent responsible for classical and acquired immunodeficiency disease syndrome (AIDS)-related Kaposi's sarcoma (KS), as well as other lymphoproliferative disorders (LPDs) in immunocompetent and human immunodeficiency virus (HIV)-infected humans. Despite all of the scientific evidence, it is difficult to fully understand ow the virus causes disease without the ability to follow a natural infection. As such, alternative in vivo models that are readily accessible and can recapitulate HHV8 infection and associated disease are absolutely needed to identify viral determinants of pathogenesis and how these specific determinants, either viral open reading frames (ORFs) or other viral-encoded macromolecules, are involved in HHV8-mediated pathogenesis. Here, we propose to utilize a closely related and relevant virus that can manifest similar biological outcomes in its natural host. The genome of the virus, rhesus rhadinovirus (RRV), has been characterized and shown to be essentially colinear and encode most of the viral ORFs thought to be associated with pathogenesis. More importantly, in vivo studies show that RRV infection of its natural host recapitulates many, if not most, of the properties of HHV8, including persistence and LPDs. The long term goal of the proposed research project is to elucidate how HHV8 interacts with its host utilizing RRV and experimental infection of its host. This will be accomplished by a series of in vivo infections and characterization of the host immune response. Additionally, the role of specific ORFs of RRV will be interrogated by creating a number of defined recombinants utilizing the RRV-bacterial artificial chromosome (RRV-BAC) that we have successfully generated and shown to be infectious and pathogenic. Combining these types of in vitro and in vivo studies to address viral pathogenesis will enable researchers to dissect how viruses cause infection and disease in susceptible populations and how scientists can shift the pendulum in favor of the host.

Public health relevance
PUBLIC HEALTH RELEVANCE: The incidence of Kaposi's sarcoma-associated herpesvirus (KSHV) infection and associated disease in the developing and developed world will continue to grow as the population becomes immunodeficient due to human immunodeficiency virus (HIV)-1 infection or iatrogenic agents associated with organ transplantation. The results of the proposed studies utilizing the nonhuman primate animal model, should help elucidate the role of the viral immune evasion genes in virus infection, persistence and disease, and provide new insights into the future development of therapies for KSHV-associated malignancies.